The role of the mRNA-based or Newcastle disease virus (NDV)-based vaccine platform in mucosal B cell priming and recirculation

PROJECT SUMMARY
The experiences and lessons learned from the COVID-19 pandemic geared our interests towards
investigating the mechanism of action of different vaccine platforms and vaccination strategies that aim to induce
long-lasting protective systemic and mucosal immune responses to prevent disease and transmission via the
mucosal route. Dr. Weina Sun co-developed a Newcastle disease virus vector (NDV)-based COVID-19 vaccine
that can be used either as an injectable inactivated whole virion vaccine or a live intranasal vaccine, the latter of
which can elicit mucosal immune responses as a “stand-alone” vaccine platform. In naïve mice, a 2-dose regimen
of intranasal NDV-based vaccine induced a high level of mucosal IgA antibodies. In mice that were pre-
vaccinated with mRNA-LNP COVID-19 vaccines via the intramuscular route, a third intranasal NDV booster also
substantially enhanced nasal wash antigen-specific IgA. By closely examining samples obtained from different
anatomical mucosal sites in mRNA-LNP vaccinated mice without the NDV booster, spike-specific IgA were
detected in nasal wash, intestinal lavage as well as vaginal lavage, among which Intestinal lavage contained the
highest levels of IgA. Dr. Jennifer Gommerman is an immunologist with special interests studying mucosal B
lymphocytes. In humans, she developed methods to detect salivary antibodies. While SARS-CoV-2 infection
induces high levels of spike-specific salivary IgG and IgA, salivary IgG are also abundantly found after
intramuscular 2-dose mRNA vaccinations. Intriguingly, some of the mRNA-vacccinated individuals developed
and maintained modest salivary secretory-IgA that were resistence to decay after a 2-dose mRNA vaccine. Given
that both in mice and humans, mucosal antigen-specific IgA were detected after mRNA-LNP vaccination, we
hypothesize that mRNA-LNP vaccines can prime de novo mucosal B cells that are close to the administration
sites, which are able to recirculate to other mucosal surfaces. Consequently, a further mucosal booster vaccine,
such as the intranasal live NDVvaccine, would be able to recall pre-exisiting memory B cell responses. We will
follow two specific aims to test our hypothesis, utilizing mRNA-LNP vaccine and NDV vaccine encoding the
spike of Beta variant as a proof of concept: (Aim 1) To examine temporal and spatial dynamics of antigen-specific
IgA and IgG secreting B cells in the mucosa-associated lymphoid tissues after mRNA and NDV vaccination in
mice. (Aim 2) To track circulation of antigen-specific mucosal B cells in photoconvertible Kikume mice after mRNA
prime followed by NDV vaccination or infection by flowcytometry. The proposed work entails innovative
approaches and mouse models to test our hypothesis. We believe the outcomes of the study can inform the
mechanism of action of not only mRNA-based and NDV-based SARS-CoV-2 vaccines, but also the same types
of vaccines against other respiratory or enteric viral pathogens, in which mucosal antibody responses plays a
critical role to mitigate virus infection and transmission.

Public health relevance
Project narrative The proposed research is in support of needs to investigate the role of different types of vaccines including the systemic intramuscular mRNA and the intranasal Newcastle disease virus (NDV)-based viral vector vaccine at priming and shaping mucosal B cells responses. In this project, we will use a wild type mouse model and a photoconvertible Kikume mouse model with the same genetic background to study the temporal and spatial dynamics of plasma cells and memory B cells development and to track the redistribution of primed mucosal B cells in animals vaccinated by stand- alone mRNA vaccine, NDV vaccine or an mRNA “prime” followed by an NDV “pull” regimen.